Development and Feasibility Testing of a Multi-Component Intervention to Increase HIV Testing and Linkage to Services among MSM in Peru

SUMMARY/ABSTRACT
Despite the scale-up of free antiretroviral treatment (ART), HIV incidence among men who have sex with men
(MSM) in Perú remains high. Delayed diagnosis and suboptimal linkage to care are two important factors driving
onward transmission. New strategies to increase rates of testing and promote timely linkage to HIV treatment
and prevention are greatly needed. Venue-based testing and mobile health (mHealth) are two promising
strategies that could address these challenges by mitigating key barriers to care experienced by MSM in Perú.
Based on our previous work, offering HIV testing at social venues (e.g. bars/discos, public plazas) in Lima is
acceptable and identifies MSM with previously undiagnosed HIV infection. Extending this to sex-on-premises
venues (SOPVs: saunas, sex clubs, hourly hotels) could reach a particularly vulnerable sub-population of MSM,
including those not reached by clinic-based testing. One potential pitfall of venue-based HIV testing is low linkage
to care among newly diagnosed HIV+ individuals. WelTel is an evidence-based mHealth platform that may be
well-suited to assist by adapting its theory-guided two-way messaging approach to support linkage to care – and
prevention – among MSM reached for HIV testing at SOPVs. In this proposal we will develop, refine, and
conduct feasibility testing of a multi-component HIV testing and linkage-to-services intervention for MSM
in Perú, consisting of two core components: 1) SOPV-based HIV testing and 2) “AppSalud”, a novel tailored
application of WelTel to facilitate linkage to HIV services. In AIM 1, we will conduct formative research with the
target population and key stakeholders to guide development of the intervention. In AIM 2, we will develop
AppSalud by reconfiguring WelTel with new tailored content, then beta test it with both potential user types: (a)
MSM, and (b) providers at HIV clinics in Lima (to test the provider interface). Guided by the “mCFIR”, a mHealth-
specific version of the Consolidated Framework for Implementation Research (CFIR), we will conduct a mixed
methods analysis exploring potential implementation barriers and facilitators for AppSalud from the perspectives
of both MSM and providers. In AIM 3, we will conduct a feasibility trial of the multi-component intervention (SOPV-
based HIV testing plus AppSalud), comparing 3 HIV testing formats: rapid point-of-care testing (POCT), home
based self-testing (HBST), and referral for clinic-based testing (RCBT). Supported by a team of experienced
international HIV investigators and outstanding institutions in both the U.S. and Perú, these studies constitute
the mentored clinical research component of the candidate’s career development plan. In parallel with this
research, the candidate will pursue additional training in implementation science, qualitative/mixed methods,
mHealth, and intervention trials, guided by a multidisciplinary team of committed mentors with expertise in
each of these areas. The training and mentored research made possible by this K23 Award will launch the
candidate’s career as an independent investigator poised to achieve his long-term goal of becoming a leading
HIV researcher developing evidence-based strategies to optimize HIV prevention and care globally.

Public health relevance
PROJECT NARRATIVE HIV incidence remains high among men who have sex with men (MSM) in Perú, and has not significantly changed despite the scale-up of antiretroviral treatment access over the last decade. New strategies are needed to increase access to HIV testing and promote timely linkage to treatment and prevention services in this population. In this project, we will develop, refine, and conduct feasibility testing of a multi-component intervention to support HIV testing and linkage to services among MSM in Perú.